QUANTITATION OF PROSTATIC ANDROGENS USING BIOPSY SPECIMENS

Dihydrotestosterone (DHT) tissue levels are sensitive indicators of androgenic activity in the prostate (P). P-tissue DHT has been previously studied using whole P or large quantities of surgically excised P tissue. We tested the hypothesis that, using a modification of our existing assay methods, tissue levels of DHT and testosterone (T) can be quantified in P biopsies (Bx) weighing as little as a few mg. Prostate samples (mean weight 7.6 mg, range 1.5 to 16.2 mg) were obtained from 20 men (mean age 68 yr) with benign prostatic hyperplasia (BPH), who were undergoing 18 ga needle Bx to rule out cancer (N=16) or transurethral resection for relief of obstruction (N=4). Seven men were on long-term Finasteride therapy (a 5` reductase inhibitor) and 13 were untreated controls. Specimens were flash frozen on dry ice and stored at -80C until assayed. Tissues were mechanically homogenized, extracted with diethyl ether, and T and DHT separated by Sephadex LH-20 chromatography prior to radioimmunoassay (RIA). Matched serum samples were extracted, chromatographed and assayed for T and DHT in parallel with the tissue samples. Tissue DHT was significantly reduced (p < 0.01) by 70% in Finasterid-treated men compared to controls (4.89 q 2.1 vs 1.42 q 0.9 ng/g tissue) whereas tissue T was increased by approximately the same amount (1.89 q 1.1 in Finasteride group vs 4.91 q 3.3) in the control group. Serum DHT was also significantly reduced under Finasteride therapy (0.48 q 0.24 vs 0.14 q 0.9 ng/ml). These data were virtually identical to those seen when much larger quantities of tissue were assayed in similar clinical circumstances. This method may be useful in testing new BPH therapies by permitting direct, longitudinal analysis of changing androgen status within the prostate.